2020 APS Institute on Teaching and Learning

2020 APS Institute on Teaching and Learning Project Summary/Abstract The American Physiological Society (APS) will present the 2020 Institute on Teaching and Learning (ITL) from June 22-26, 2020 at the University of Minnesota, Minneapolis. This biennial conference features best practices in evidence-based teaching and learning and assists faculty and trainees in the development of publishable educational research initiatives. The 2020 ITL conference will include presentations from multiple established researchers and educators, who will serve both as speakers at the institute and as facilitators of interactive workshop activities that will include modeling of innovative teaching techniques. Many of these presenters will bring their expertise from outside the field of physiology to ITL participants. The ITL provides an opportunity for networking and the exchange of breakthrough ideas and best practices in physiology education. In addition, we hope to use the 2020 conference as a training opportunity for graduate fellows to develop their careers through participation in a mentorship program focused on practical skills training and career development. This is a group in which explicit training and opportunities in teaching are rarely available in their home institutions The 2020 ITL will engage physiologists from diverse institutions both in the US and worldwide that reach underserved students and students across the education spectrum, including undergraduate, graduate, and professional levels; and provides support for collaborations among new and experienced educators by establishing a critical communication forum across educational levels.

Public health relevance
2020 APS Institute on Teaching and Learning Project Narrative This biennial conference features best practices in evidence-based teaching and learning and assists physiology faculty and trainees in the development of publishable educational research initiatives. The 2020 ITL conference will include presentations from several established researchers, who will serve both as keynote speakers at the institute and as facilitators of interactive workshop activities that will include modeling of innovative teaching techniques. In addition, we hope to use the 2020 conference as a training opportunity for graduate fellows to develop their careers through participation in a mentorship program focused on practical skills training and career development.